The Interplay of Neuronal Activity and Synaptic Abnormalities and their Restoration through Mitochondria in Alzheimer's Disease

Summary
Alzheimer's disease, a leading cause of dementia, is characterized by synaptic dysfunction and aberrant
neural activity contributing to cognitive decline, with mitochondria being an early target of amyloid pathology.
This sets off a vicious cycle involving synapses, neural activity, and mitochondria, which may differ depending
on age and brain region. This proposal seeks to investigate the interconnectedness of these factors in an age-
dependent manner across multiple brain regions. By utilizing mouse models of Alzheimer's disease, the study
aims to determine whether modulation of neural activity, synapses, or mitochondria could enhance neural
plasticity in amyloidosis. Through a combination of in vivo and ex vivo approaches, the proposal aims to
unravel the relationship between neural activity and synaptic abnormalities and test the efficacy of targeting
Cyclophilin D, a component of the mitochondrial membrane permeability transition pore, in improving
mitochondrial health and reversing synaptic and neural activity deficits.

Public health relevance
PROJECT NARRATIVE The cognitive decline in Alzheimer’s disease is associated with synapse loss and aberrant neural activity, both of which are impacted by disrupted mitochondrial function. This project investigates the relationship between structural synaptic abnormalities, aberrant neural activity, and mitochondrial stress in vivo in mouse models of Alzheimer’s disease. The project aims to improve mitochondrial health using genetic and pharmacological manipulations to normalize synaptic and neural activity plasticity in amyloidosis.